HEMOGLOBIN-OXYGEN EQUILIBRIUM STUDIES

We have recently acquired The Hemox Analyzer which enables automatic recording of oxygen equilibrium curves of whole blood and isolated hemoglobins. This system will be utilized in determining: 1) Oxygen equilibrium curves as well as the determination of a number of important and relevant variables such as hemoglobin cooperativity, Boher effect, temperature effect, etc. for a number of chemically modified hemoglobin preparations. 2) Whole blood oxygen equilibrium curves in samples from adult sickle cell patients undergoing treatment with a combination therapy of recombinant erythropoietin and hydroxyurea. The effect of increased fetal hemoglobin synthesis ( a result of EPO/HU administration) on oxygen binding characteristics of the intraerythrocytic hemoglobin S will be determined. This specific part of the project will be carried out here at our lab in collaboration with Drs. G. Rodgers and A Schechter from the Lab of Cell Biology, NIDDK, Bldg. 10.